Genetic variation in the metal transporter ZIP8 and impact on the innate immune response in the gut

PROJECT ABSTRACT
Inflammatory bowel diseases (IBD), including Crohn’s disease (CD) and ulcerative colitis, affect 1 in
200 Americans. IBD arises through a complex interplay of genetic, immune, microbial, and environmental
factors disrupting intestinal homeostasis. There is a strong call from patients to study the role of diet-derived
micronutrients in intestinal homeostasis. Recent genetic studies have focused attention on ZIP8 and the role of
metal transport in CD through the discovery of an association between CD and a nonsynonymous single
nucleotide polymorphism (SNP, rs13107325; Ala391Thr) in SLC39A8, the gene encoding ZIP8. This SNP has
also been associated with six other diseases, including obesity and schizophrenia. Further, individuals with
ZIP8 A391T shared a common fecal dysbiosis independent of disease diagnosis. The function of ZIP8 in the
gut is not known, but in other cell types, ZIP8-mediated zinc transport into the cytoplasm results in negative
regulation of NF-κB signaling. Our preliminary data demonstrate that ZIP8 is increased in the inflamed terminal
ileum of patients with CD and localizes to the apical membrane in intestinal epithelial cells. We have
established a model system using ileal enteroids to study ZIP8 biology. We hypothesize ZIP8 and ZIP8-
mediated zinc transport regulates the innate immune response and host-microbiota interaction in intestinal
epithelial cells, and this function is changed by ZIP8 A391T to promote CD pathogenesis. The aims of this
project are (1) To establish the role of ZIP8 in intestinal epithelial cells in the innate immune response, (2) To
study the effect of CD-associated genetic variation in ZIP8 (A391T) on ZIP8 function in intestinal epithelial
cells, and (3) To examine the role of ZIP8 in host-microbiota interactions. We will accomplish these aims by
molecular genetics and microbiology techniques using human ileal enteroids as the in vitro model system. The
candidate is an Assistant Professor of Medicine at the Johns Hopkins School of Medicine in the Division of
Gastroenterology with research and clinical training dedicated to IBD. The short-term goal for this applicant is
to use this project to enhance her molecular biology, immunology, and microbiology expertise and position her
to build an independent career as a physician-scientist merging these disciplines to study the role of
micronutrients in the pathophysiology of IBD. In addition to hands-on training and didactic education, the
Training Plan includes strong mentorship from a Scientific Advisory Committee with diverse expertise in
epithelial biology, microbiology, zinc biology, NF-κB signaling, host-microbiota interactions and IBD,
complemented by the strong support of the Hopkins Conte Digestive Diseases Basic and Translational
Research Core Center and the institution.

Public health relevance
PROJECT NARRATIVE Inflammatory bowel diseases affect 1 in 200 Americans, but studying the mechanisms underlying why these diseases occur informs our greater understanding of how the gastrointestinal tract maintains homeostasis despite the constant presence of microbial and dietary antigens. This project will examine the role of a metal transporter, ZIP8, with a genetic mutation that has been associated with Crohn’s disease, as well as schizophrenia and obesity, suggesting shared pathogenic mechanisms. By studying the role of this zinc and manganese transporter in the innate immune response in the gut with both in vitro and in vivo models, we hope to understand why the disease-associated mutation promotes inflammation.